Utilization of a Social Network Approach To Examine The School-To-Work Transition: Examination of High-Risk Work Environments

ABSTRACT
Alcohol misuse and its consequences peaks during emerging adulthood (the period of life between the ages of
18 to 25). Concurrently, during this time, many individuals head into the workforce. While previous research
has documented that there are certain occupations that are associated with alcohol misuse, little is known
about how newcomers’ alcohol use changes when entering these occupations that are characterized as high-risk
for alcohol misuse. Guided by the organizational socialization literature and social learning theory, the
proposed project aims to provide a better understanding of the transition into these high-risk occupations for
alcohol misuse and to examine how the social environment influences alcohol use. A national sample of
emerging adults (N= 400) before they start at high-risk occupations for alcohol misuse will be recruited. The
five high-risk work occupations for alcohol misuse are the following: 1) construction and extraction, 2)
installation, maintenance, and repair, 3) food preparation and serving related, 4) transportation and material-
moving, and 5) sales and related occupations. Participants will be followed over 2 years, in which they will
complete 7 assessments and 5 one-week “bursts” of daily diary assessments. Participants will report on the
characteristics of the work environment, including the amount of alcohol use among coworkers and managers
at work, and their own alcohol use. Findings from this study will inform prevention and intervention efforts to
reduce heavy drinking and alcohol-related consequences. High-risk work environments for alcohol use could
provide training on alcohol use, which would be beneficial to the organization (e.g., by reducing absenteeism,
turnover, etc.) and the individual (e.g., reducing alcohol-related consequences). Furthermore, most prevention
efforts for young adults occur in college settings and ignore those who head directly into the workforce thus
putting those that head directly into the workforce after high school at risk.

Public health relevance
Project Narrative: Public Health Relevance Statement During emerging adulthood, alcohol misuse peaks and many individuals start to develop problems with alcohol. While most research on alcohol misuse during this period examines the college context, there are specific work occupations where alcohol misuse is prominent. Thus, the proposed investigation will examine the trajectories of emerging adults entering these high-risk occupations and how the composition of the social network at work contributes to alcohol misuse, which will inform prevention and intervention efforts to reduce heavy drinking and alcohol-related consequences.